PLASTIC FILM SUPPORTED DNA SEQUENCING GELS

This project will prepare thin polyacrylamide gels for DNA sequencing, substituting plastic film for glass plates as the supporting material. This will allow preparation of ready-to-use gels, and form the basis of a useful manufacturing process. Also eliminated will be manual preparation of gels for DNA sequencing, a time-consuming and tedious step. Several approaches will be used to ensure complete gel polymerization on polyester films. The ultimate goal, following Phase I, is to design and construct a system to manufacture pre-cast gels.